Improving Glycemic Control with Electrical Stimulation in Mexican-Americans

PROJECT ABSTRACT/SUMMARY
Over the few decades, metabolic diseases such as obesity, insulin resistance, and type 2 diabetes have risen
to epidemic proportions, particularly among Mexican-Americans, and are leading to a high health care costs
nationwide. Meanwhile, adherence to physical activity to prevent these metabolic diseases has declined. A
majority (80%) of adults in the US do not meet the ACSM-recommended 150 minutes of moderate or 75
minutes of vigorous exercise per week. Mexican-Americans have greater prevalence of physical inactivity
compared to the general population. Therefore, it is critical to develop additional strategies to increase
adoption and adherence to physical activity in this at-risk population. The long-term goal of our research is to
explore effective strategies to improve glycemic control, insulin sensitivity and metabolic health in sedentary
humans, particularly those who are unable to exercise or are at risk for developing T2D. Neuromuscular
Electrical Stimulation (e-stim) is a practical, non-invasive, cost-effective and innovative method to promote an
alternative mode of muscle contraction among individuals who are less likely to engage in conventional
physical activity. Over the past decade, we have developed and established in vitro exercise models using e-
stim to contract human primary muscle cells (myotubes) to study the mechanisms by which muscle contraction
positively influences insulin sensitivity and lipid metabolism. Although e-stim is widely used in rehabilitation
settings to prevent muscle loss, there is a gap in the literature defining the effectiveness of e-stim to
improve insulin sensitivity and metabolic health. Our preliminary data and existing literature indicate a
promising application of e-stim to improve glycemic control, insulin sensitivity and metabolic health in an at-risk
sedentary, overweight or obese population. Based on our preliminary data, we propose to perform a
comprehensive randomized controlled trial (n=30) to determine the effects of 8 weeks of e-stim, on glycemic
control as measured by continuous glucose monitoring, insulin sensitivity by oral glucose tolerance test, energy
metabolism (resting metabolic rate, substrate utilization, blood lipid and metabolic profile), body composition,
and muscle strength in an at-risk, sedentary, overweight/obese, Mexican-American population. We
hypothesize that e-stim will improve 24 hour. glycemic control, increase insulin sensitivity, and improve overall
metabolic health in this population. This study will allow us to evaluate the feasibility of using e-stim as a novel
preventative treatment for insulin resistance and metabolic diseases in a sedentary population and will lay the
foundation for a larger clinical trial with potential to impact clinical practice to prevent and treat type 2 diabetes.

Public health relevance
PROJECT NARRATIVE Although exercise is highly effective in improving insulin sensitivity and metabolic health, the majority (80%) of adults in the US do not meet recommended weekly physical activity level guidelines resulting in type 2 diabetes in epidemic proportions over the past few decades. Electrical stimulation (e-stim) offers an easily adhered to and practical means to enhance metabolic health in populations with particularly low adherence to physical activity (Mexican Americans); however, the extent to which e-stim is effective is not known. In this clinical trial, we will determine the effects of neuromuscular electrical stimulation (e-stim) as a novel alternative strategy to increase glycemic control, insulin sensitivity and metabolic health in an at-risk sedentary overweight/obese Mexican-American population.